Cardioembolism as a Mechanism of Central Retinal Artery Occlusion

ABSTRACT
This is an application for an Administrative Supplement to Promote Research Continuity and Retention of NIH
Mentored Career Development (K) Award recipients. The purpose is to provide the principal investigator, Dr.
Brian Mac Grory, with the support necessary to maintain his research output during a period of paternity leave.
Dr. Mac Grory is a vascular neurology investigator pursuing patient-oriented clinical research focused on the
identification of novel populations with underexplored cerebrovascular disorders requiring personalized
secondary prevention strategies. Based on compelling preliminary data and recent publications, the central
hypothesis of this proposal is that central retinal artery occlusion (CRAO) – a form of ischemic stroke affecting
the retina – may be an indicator of underlying cardiac disease and a sentinel of future, potentially lethal,
cardioembolic stroke. CRAO is formally recognized as a form of ischemic stroke but there is an incomplete
understanding of its mechanistic underpinnings, with most research to-date focused on its association with
carotid artery stenosis. The parent K23 award proposes to generate key preliminary data linking CRAO with
cardioembolic substrates and set the stage for a future, multi-center, observational study that will definitively
test this hypothesis. Dr. Mac Grory will leverage a very large population-based dataset (the Medicare 5%
Sample) as well as both retrospective and prospective institutional cohorts. Specific Aims 1A & 1B will
determine the association of each of atrial fibrillation and left ventricular failure with the development of CRAO
and comprise the focus of the current application for an Administrative Supplement. Specific Aims 2A & 2B
will determine the association of cardiac, serum and ultrasonographic biomarkers of embolic risk with CRAO
and their interplay with carotid artery stenosis. As part of this proposal, Dr. Mac Grory will undertake a linked,
didactic training plan with the goal of developing as an independent investigator through acquisition of the
following key skills: 1) Biostatistics in observational research including advanced causal inference
methodology, 2) Data science applied to administrative claims databases, 3) Prospective, observational study
design, and 4) Vascular biomarker interpretation. Advanced training in these areas will permit Dr. Mac Grory to
realize his long-term career goal of becoming an independent clinical investigator who leverages
interdisciplinary expertise to provide insights in to the management of understudied cerebrovascular disorders.
In pursuit of this goal, Dr. Mac Grory has assembled a mentoring team with distinct though complementary
skillsets in stroke medicine, comparative effectiveness research, causal inference methodology, cardiac
electrophysiology, and neuro-ophthalmology. With the preliminary data and training obtained from the
proposed research, Dr. Mac Grory will be uniquely equipped to execute future, larger-scale studies uncovering
novel populations in whom evidence-based, potentially life-saving secondary prevention strategies may be
deployed. The scientific goals and approach remain unchanged from the original proposal.

Public health relevance
PROJECT NARRATIVE Strokes caused by blood clots coming from the heart are the most feared types of stroke and cause a high rate of death and disability. Central retinal artery occlusion (CRAO) is a type of ischemic stroke affecting the back of the eye whose mechanisms are poorly understood. The objective of this study is to clarify the relationship between disorders causing clotting in the heart and CRAO and, in doing so, identify a new group of patients who are vulnerable to future, preventable strokes from the heart.